Research Education Component

Project Summary: Research Education Component!
The OADRC Research Education Component (REC) will provide a crucible for securing and advancing the
needed research workforce into the future, continuing the OADRC’s strong history of fostering the development
of gifted researchers, facilitated by unique resources, faculty and programs for education and training. The
REC provides a unique opportunity to bring together, in a comprehensive and concerted way, faculty,
educational programs and experience for early-stage researchers to ultimately produce the best of translational
research. The primary objective guiding this REC is to prepare skilled scientists for a successful career in
Alzheimer’s and related dementias (ADRD) research. Consistent with the NIH Alzheimer’s Disease Centers
Panel Recommendations,[1] we seek to recruit early-stage scientists into the ADRD research field, provide
them with a well-rounded educational experience, and instill in them a passion for this work. Our REC will be
attuned to providing a Personalized Research Education Component Inspiring Science Excellence-- a
“PRECISE”, customized program that will serve each scholar throughout their career. We will provide training
opportunities to enrich and deepen their understanding of dementia and equip them with superb skills in
writing, analysis and the conduct of translational science, and include mentoring in scientific design and
implementation, professional comportment, and early faculty adaptation.
With this background and context in mind, the OADRC REC’s four Specific Aims are to:
1. Provide a tailored educational program utilizing didactic, experiential and individualized mentored
opportunities (lectures, seminars, courses, one-on-one coaching, real-life laboratory and clinical
activities) that cover a range of important skills and proficiencies: knowledge of foundational reference
content for the field, ethical conduct of research, culturally relevant research, good research habits and
practice, research design and methodology, grant and manuscript writing, presentation skills,
collaboration and data sharing, and leadership acumen.
2. Establish, engage and coordinate transdisciplinary faculty to support and mentor diverse early-stage
scientists in ADRD research.
3. Identify and engage early career scholars with an emphasis on recruiting individuals in the post-
doctoral period as REC program scholars with a strong focus on involving those under-represented in
ADRD research.
4. Carefully and iteratively evaluate the progress and refine the delivery of the REC program’s educational
structure, processes, and outcomes.